BRAINSTEM RESPIRATORY NEURON INTERACTIONS

The goal of the proposed research is to define the brainstem neural network that provides the central respiratory drive to the motor neurons and muscles of breathing and determine how the network is modulated by carotid baroreceptors and chemoreceptors. Planned experiments address five hypotheses. 1. A hierarchy of multiple network mechanisms contributes to both the development and termination of each phase of breathing. A distributed system incorporates multiple local networks, each sufficient to generate rhythmic activity, but with less adaptability than the whole. 2. Modulation of respiratory drive by carotid baroreceptor activity is mediated by midline and lateral medullary and pontine neural networks operating a parallel. 3. Neurons of the nucleus of the solitary tract distribute peripheral chemoreceptor information concurrently to midline raphe, lateral medullary, and pontine respiratory neurons via divergent parallel projections. Prolonged peripheral chemoreceptor activity reorganizes the functional connectivity among these brainstem regions and potentiates the respiratory drive to phrenic motoneurons. Changes in the synchronous activity of neural assemblies without corresponding changes in mean firing constitutes one mechanism for modulating respiratory activity. 4. Intrinsic brainstem mechanisms and pulmonary stretch receptor feedback jointly provide signals to generate respiratory "gating" of the baroreceptor and chemoreceptor reflex actions. 5. The "multi-layered" topology of medullary-pontine neuron projections serves as a spatially distributed redundant fault tolerant respiratory coordinating mechanism. Experiments will be performed with anesthetized or decerebrate artificially ventilated cats. Pulmonary stretch receptors and carotid baro- and chemoreceptors will be selectively stimulated to perturb respiratory related neural activity while as many as 30 respiratory neurons in five different brainstem regions are monitored simultaneously. These many- neuron recordings and advanced quantitative analytical methods will be used to detect and evaluate functional connectivity and cooperative interactions. These results will define parameters required for neural network simulations designed to establish whether models derived from the animal experiments are plausible and sufficient to generate observed network behavior. This work will contribute to our understanding of the control of breathing and two broader questions: (1) How does the brain process information in parallel? (2) How does the brain reorganize to produce adaptive responses?